Visualization of gene activity in the Drosophila embryo

Project Summary Abstract
How remote transcriptional enhancers communicate with their target promoters to regulate gene activity
persists as one of the central mysteries in cell and developmental biology. Classical models envisioned
the formation of chromosomal loops that result in direct physical association of enhancers and promoters.
However, there is emerging evidence that large distances (~200 nm) separate enhancers and promoters
during transcription activation. Moreover, shared enhancers can co-activate linked genes, both in cis and
in trans across homologous chromosomes. These observations are not obviously compatible with classical
models and have prompted an alternate view, “transcription hubs”, whereby enhancers and promoters
recruit large clusters or condensates of transcriptional activators. A major goal of the proposed study is to
determine the role of insulator DNAs and tethering elements in the formation and function of transcription
hubs. Insulators function as boundary elements when interposed between a distal enhancer and target
promoter. They also foster the formation of topological associating domains (TADs) and paring of alleles
located on different homologous chromosomes. In Drosophila, tethering elements are GAGA-rich
sequences that facilitate long-range enhancer-promoter interactions.
We will employ a combination of genome editing, Micro-C XL assays, and quantitative live imaging
methods in living Drosophila embryos to visualize even subtle changes in the timing and levels of gene
expression arising from mutations, inversions, and deletions of defined insulators and tethering elements.
Particular efforts will focus on long-range enhancer-promoter communication within complex genetic loci.
For example, we will examine the role of tethering elements in the activation of Scr transcription by a
remote enhancer that must bypass an intervening TAD within the Antennapedia Hox gene complex. We
will also explore the contributions of individual insulators and tethering elements for the co-regulation of
linked genes by shared enhancers over distances of 75 kb and 235 kb in the knirps and Scylla loci,
respectively. Finally, we will examine the possibility that low complexity sequences in tethering factors
(e.g., Trithorax-like) contribute to the stability of enhancer-promoter loops by nucleating the formation of
activation condensates. These studies have the potential to unravel current controversies regarding the
importance of insulators, TADs, and tethering elements in gene regulation during development. They might
also reveal new connections between chromosomal loops and the formation of transcriptional hubs.

Public health relevance
Project Narrative How transcriptional enhancers communicate with their target promoters persists as one of the central mysteries in cell and developmental biology. We will employ a combination of genome editing, Hi-C contact maps, and quantitative imaging methods to explore the role of chromosomal looping elements--insulators and tethering elements--in the regulation of gene expression in the Drosophila embryo. We will test the hypothesis that looping factors stabilize enhancer-promoter associations by nucleating the formation of transcription hubs: clusters or condensates of transcription factors and RNA Pol II.